The Development and Pilot Testing of a Caregiver-Child Shared Decision-Making Intervention to Improve Asthma in Urban Youth

PROJECT SUMMARY / ABSTRACT
Background and Rationale: Minority children experience high asthma prevalence and morbidity. Asthma self-
management can achieve and sustain disease control. However, urban early adolescents have sub-optimal
self-management. Notably, critical health behaviors that emerge at this age affect lifelong patterns. Therefore,
early adolescence offers a unique opportunity to intervene, allowing the youth to become effective self-
managers. Successful self-management requires the right division of responsibility between caregivers and
adolescents. Thus, intervening simultaneously with early adolescent and their caregivers who can help support
the early adolescent’s growing autonomy to self-manage asthma has the potential for a synergistic effect,
further facilitating the adolescents’ self-management, and thus asthma control. Objective: We propose to
develop and pilot test BREATHE-Peds (BRief intervention to Evaluate Asthma THErapy for Pediatrics), a novel
dyadic (caregiver-early) shared decision-making (SDM) intervention, to improve asthma control in 10- to 14-
year-old youth with asthma in federally-qualified health centers (FQHCs). Hypotheses: Hyp 1: The
intervention will be feasible and acceptable as evidenced by: high rates of dyad recruitment and retention;
primary care provider (PCP) fidelity to the treatment protocol; and PCP and caregiver-child dyad satisfaction.
Hyp 2. Over 3-months post-intervention, relative to controls, BREATHE-Peds children will have improvement in
asthma control as measured by the Asthma Control Questionnaire (primary outcome), higher perceived SDM,
reduced symptoms, missed school days and other secondary outcomes. Methods: The proposed study
includes two phases: (1) a development phase where we will develop BREATHE-Peds using focus groups with
caregiver-early adolescent dyads (n=30) and expert input, and (2) a pilot validation phase where we will
conduct a group-randomized trial in two FQHCs with 80 caregiver-early adolescent dyads treated by 8 PCPs
(4/FQHC; 10 dyads/PCP) randomized within FQHCs to 1 of 2 study arms: (a) BREATHE-Peds (n=40 dyads),
or (b) dose-matched attention control (n=40 dyads). We will follow caregiver-child dyads for 3 months post-
intervention to assess the impact of BREATHE-Peds on asthma outcomes; we will conduct post-trial interviews
with PCPs, caregivers, and their children to evaluate satisfaction with the intervention. Significance: The study
has high public health significance because it (1) tests the application of SDM to pediatric asthma; (2) targets
caregiver-early adolescent dyads, which may have a synergistic effect, (3) tests a sustainable and scalable
real-world pragmatic approach to improving asthma in FQHCs, unique primary care settings that provide safety
net services for vulnerable populations, and (4) contributes to the scientific foundation for clinical practice and
managing symptoms, thus addressing an important health inequity issue.

Public health relevance
NARRATIVE This study addresses the important problem of uncontrolled asthma among a group at high risk for asthma and its adverse effects – urban minority children. This is a trial of a brief shared decision-making intervention that primary care providers will deliver to caregivers and their children aged 10-14 during a routine office visit, focusing on improving self-management. Even modest improvements in self-management could produce better health outcomes, thus addressing an important health inequity issue in this vulnerable population.